An in vivo multiplex model to study gene-environment interaction in Parkinson's Disease

Project Summary/Abstract
Parkinson's disease (PD) is a progressive neurodegenerative disorder that is characterized by α-synuclein-rich
neuronal inclusions. Recent genome-wide associated studies (GWAS) and epidemiological studies have
identified multiple candidate genes and environmental factors, respectively, which can modify PD risk. Studying
polygenic interactions with environmental factors has been difficult due to the lack of a model system. However,
studies have hinted at a complex relationship between α-synuclein, the genetic risk factors, and environmental
factors. In our preliminary data, we have established a multiplex model using the Drosophila model of PD. In this
model, we express human α-synuclein, simultaneously modify GWAS candidate genes in neurons, and expose
adult flies to rotenone. Using a combination of scalable techniques in this model, we identified novel interactions
among α-synuclein, environmental factors, and GWAS genes. The overarching hypothesis is a multiplex
model, in combination with iPSC-derived neurons, can be used to identify and study the mechanism of
novel gene-environment interactions. Further, this model system will identify potential drug targets that
can modify the gene-environment interactions. In Aim 1, a series of experiments, including super-resolution
microscopy and iPSC-derived tyrosine hydroxylase (TH) neurons, will be performed to characterize the
interaction among LRRK2, rotenone, and α-synuclein, which was identified using the multiplex model. These
experiments will be performed in the laboratory of primary mentor Mel B. Feany. Aim 2 will involve understanding
the mechanism of interactions among LRRK2, rotenone, and α-synuclein. Previous studies and preliminary
experiments have shown that actin hyperstabilization plays a central role in regulating neurotoxicity. Herein
biochemical, immunohistological, and neurotoxicity assays will be performed in Drosophila and iPSC-derived TH
neurons (obtained disease-causing LRRK2-G2019S and protective LRRK2-R1398H iPSCs) to study the role of
actin dynamics in regulating this gene-environment interaction. These experiments will be performed in Dr.
Feany's lab. In the independent R00 section, a druggable target that can modify the interaction among LRRK2,
rotenone, and α-synuclein will be identified. Further, we will screen for other PD-related neurotoxicants that
interact with LRRK2 and α-synuclein through actin hyperstabilization. We will genetically and pharmacologically
inhibit MRCKα, a kinase that can regulate actin hyperstabilization, in flies, iPSC-derived neurons, and a mouse
model. My neurotoxicology and neurodegeneration training will be facilitated by didactic courses and
participation in Clinical Pathological conferences at Harvard Medical School and the Exposome boot camp at
Columbia University organized by co-mentor Gary Miller. This project may elucidate a novel model system that
can be used to identify and study the mechanism of gene-environment interactions. The training that I undertake
will enable me to transition to independence and lead a laboratory investigating the molecular mechanisms of
gene-environment interactions in neurodegenerative disorders.

Public health relevance
Public Health Relevance Statement: Project Narrative Due to the lack of model systems, it has been difficult to study complex gene-environment interactions in Parkinson's disease. Using a combination of Drosophila genetics and patient-derived induced pluripotent stem cells, we can develop a model that can be utilized to identify and study the mechanisms of interaction among GWAS candidate genes, environmental factors, and α-synuclein. This K99/R00 proposal aims to characterize a novel interaction among LRRK2, rotenone, and α-synuclein, study the mechanism of the interaction and subsequently validate this novel multiplex system, which can be used to study these previously unknown interactions among environmental and genetic factors and is a step towards personalized medicine.